EFFECT OF LOWER BODY NEGATIVE PRESSURE ON RENAL BLOOD VELOCITY IN NORMALS

This study aims to define the changes in renal hemodynamics induced by lower body negative pressure. The long term aim is to assess the ischemic potential of a renal artery stenosing lesion.